Multifunctional tough adhesive hydrogels to recruit, expand, and deliver tendoncells during aging and injury

Project Summary
My career goal is to become an independent investigator and educator who studies structure-function
mechanisms of tendon aging and injury and how they may be improved using biomaterials. My research training
in bioengineering started by studying the role of healing and fatigue loading on multiscale tendon properties. I
realized that knowledge of biomaterials and therapeutic delivery strategies would be essential to develop
treatments for tendon. During my F32 postdoctoral training, we have developed and explored the capacity of
tough adhesive biomaterials, inspired by the mucus secreted by slugs, to adhere strongly to tendon surfaces.
The goal of this tough adhesive biomaterial is to provide mechanical support and a template for tendon
regeneration, serve as a depot for local delivery of agents, support cell growth and infiltration, and provide gliding
of surrounding tissues. This K99/R00 Application examines a new cell delivery strategy to dynamically recruit
cells in vivo, expand them, and release them on-demand to promote tendon healing using this biomaterial
platform. My mentoring team consists of Dr. David Mooney (primary mentor) and seven other renowned
scientists specializing in tendon developmental and aging biology, musculoskeletal biology, drug delivery,
orthopaedic bioengineering, materials science, and orthopaedic surgery. They provide me with an exceptional
environment to investigate these questions and develop the necessary skills to contribute to the field as an
independent investigator. We hypothesize that this biomaterial system can be tuned to recruit, expand, and
deliver tendon cells (using tough adhesive hydrogels) and augment tendon properties during aging and injury.
This hypothesis will be tested with the following aims: (1) develop and examine the ability of tough hydrogels
containing chemotactic agents to recruit tendon-derived cells, promote their proliferation, and increase
expression of tendon markers throughout aging and injury in vitro and in vivo; (2) develop and examine the ability
of hydrogel degradation and embedded fibers to template mature tendon, drive expression of tendon markers,
and promote cell release from the scaffold to the injury site throughout aging and injury, in vitro and in vivo; and
(3) investigate the ability of the tough adhesive hydrogel system to restore age-related deficits in tendon
homeostasis and healing using a clinically-relevant Achilles tendon rodent model. Success would have a
dramatic impact on individuals suffering from tendon dysfunction following injury and could contribute to the
development of on-demand therapeutics for other musculoskeletal and connective tissue diseases. Overall, this
comprehensive project and training plan will provide me outstanding training to develop the technical and
professional skills necessary to establish a successful and independent research program to study and provide
mentoring in musculoskeletal tissue aging and biomaterials.

Public health relevance
Project Narrative This K99/R00 application describes a mentoring strategy for Dr. Benjamin Freedman to gain the necessary aging biology, biomaterials, and drug delivery skill set to develop and evaluate a new cell delivery approach to augment tendon. With increased participation in recreational activities and sport, and a more active aging population, the incidence of acute and chronic tendon injuries is rising. In this project, we will develop and examine how biomaterials can dynamically recruit, expand, and release cells in vivo, which will yield improved cell delivery strategies for tendon injuries throughout aging and have broad applications to other tissues and disease states.